Chemical Strategies to Reveal Cellular Glycation and Ubiquitination

Protein post-translational modification (PTM) networks are tremendously promising, but vast, frontiers for drug
discovery. It is therefore essential to learn how specific PTMs are integrated into signaling networks in living
cells. To address this need, the Scheck lab pioneers new chemical biology tools that will provide critical insight
about PTM networks in living cells. Our focus is on PTMs like glycation and ubiquitination, which have been
particularly difficult to study using traditional tools that inhibit or profile specific enzyme activities through genetic
knockout or pharmacologic inhibition. Our novel methods will unlock previously unattainable information that will
be used to address longstanding questions about the role of glycation, ubiquitination—and their interplay—in
diabetes, cancer, inflammation, neurodegenerative disease, and other age-related disorders. Learning how
these signals are integrated into cellular signaling processes will provide access to new targets for preventing or
treating numerous diseases.
This MIRA project describes chemical strategies that rely on our knowledge of PTM chemistry and mechanism,
making us uniquely suited to develop needed methods to track specific glycation or ubiquitination events in living
cells. One series of projects builds on our significant published and unpublished work that has uncovered the
chemical and molecular features that underpin selective glycation, enabling us to create a novel tool (called
dialAGE) that predictably modulates site-specific glycation events in living cells. The proposed studies include
the use of deuterated methylglyoxal probes to differentiate previously indistinguishable AGE isomers using
unbiased quantitative proteomics. We will also evaluate how differential ubiquitin glycation influences the global
ubiquitinome and learn how it influences protein turnover through proteasomal or autophagic pathways. We will
also create a new set of dialAGE tools to manipulate histone glycation, enabling studies that will reveal how
glycation influences chromatin compaction, PTM crosstalk, and in vitro transcription. Another series of projects
builds on a new tool we recently reported, called targeted Charging of Ubiquitin to E2 (tCUbE), that tracks the
fate of ubiquitin through its sequential E1-E2-E3 cascade all the way to its ultimate target. The proposed studies
will optimize tCUbE as an enabling technology that can be broadly used to profile each of the 38 known human
E2s. We will also use tCUbE to interrogate specific E2s, such as UBE2L3, which we hypothesize to exhibit
multiple activities that differentially engage disease-relevant signaling pathways. Uncovering new E2-substrate
interactions or cascades will enable discovery of targeted degradation or stabilization therapies to disrupt or
rewire specific steps within the UPS. Together, this work will uncover direct links between glycation,
ubiquitination, and critical intracellular processes, including proteasomal degradation, mitophagy, and chromatin
remodeling. These studies will dramatically improve our understanding of glycation and ubiquitination, and will
have an immediate impact on our appreciation for how they influence human health, aging, and disease.

Public health relevance
Project Narrative Protein post-translational modifications like glycation and ubiquitination are associated with many diseases, including cancer, diabetes, neurodegenerative disease, and age-related disorders. The proposed work will provide greatly needed methods to uncover direct links between these modifications and disease relevant changes in cellular signaling. Learning how these signals are interpreted or degraded will provide access to a wealth of new potential therapeutic targets for preventing or treating numerous diseases.